Fecal Microbiota Transplantation and Fiber for the Treatment of Graft-versus-host Disease After Hematopoietic Cell Transplantation

PROJECT SUMMARY
Allogeneic hematopoietic cell transplantation (HCT) is a life-saving treatment for hematologic malignancies that
remains the treatment of choice for conditions such as high risk leukemias. Graft-versus-host disease (GvHD) is
a common complication of allogeneic HCT, affecting >50% of patients. Despite decades of progress in
transplantation biology, we have limited treatment options for this common condition associated with substantial
morbidity and mortality. GvHD has been linked to loss of gut bacterial diversity and changes in bacterial
community composition after HCT. There is compelling evidence from antibiotic intervention studies in animals
and humans that manipulation of the gut microbiota influences subsequent risk of GvHD. Observational studies
of fecal microbiota transplantation (FMT) have generated intriguing data suggesting that FMT is a promising
intervention for safely repopulating the gut microbiota in HCT recipients with GvHD. However, the effect of FMT
delivery route on microbial reconstitution has not been investigated in a controlled manner, the role of dietary
supplementation on maintaining a beneficial gut microbiota after FMT remains unexplored in this population, and
there is limited insight into mechanisms for how the microbiota may impact clinical outcomes after FMT. For
example, administering FMT via oral capsules may seed a larger area of the intestinal tract yielding more durable
changes in gut microbial colonization, but conversely could lead to loss of functionally important bacterial species
through killing by gastric acid and bile salts in the upper tract. Similarly, colonization efficiency may be enhanced
by providing bacteria with key nutrients such as dietary fiber. In addition, dietary fiber is a substrate for bacterial
production of short chain fatty acids such as butyrate linked to immune modulation and intestinal health. It is
unknown if dietary fiber supplementation enhances microbiological engraftment after FMT in these patients or
fosters a metabolic environment that promotes healing after HCT related gut injury. There are no published
randomized controlled trials of FMT for treatment of GvHD. Our proposed F2 study (FMT x Fiber) in patients with
gut GvHD will investigate how route of FMT (oral capsule, upper vs. colonic instillation, lower) and dietary fiber
supplementation influence reconstitution of a beneficial microbiota. This study will feature frequent stool
sampling, robust analysis of bacterial community composition and metagenomic content in stool, evaluation of
the impact of the interventions on recovery of T-cell subsets in blood with known associations with GvHD,
assessment of metabolites such as short chain fatty acids produced by the gut microbiota that may ameliorate
GvHD, and follow-up to assess resolution of GvHD symptoms, stage, and grade. These in-depth longitudinal
microbial, metabolic, nutritional, immunological, and clinical data will allow a much-needed, mechanistic
investigation of how a beneficial gut microbiome can be optimally restored and maintained through FMT for
treatment of GvHD.

Public health relevance
PROJECT NARRATIVE Graft-versus-host disease (GvHD) is a common complication of allogeneic hematopoietic cell transplantation (HCT) associated with substantial morbidity and mortality. GvHD has been linked to loss of gut bacterial diversity and changes in bacterial community composition that commonly occur after HCT. This study seeks to determine the optimal method for restoring gut bacterial diversity using fecal microbiota transplantation from normal donors and supplemental dietary fiber, with the ultimate goal of advancing our understanding of mechanisms for microbe-mediated attenuation of GvHD.